A prospective multiethnic HFpEF cohort from California's Central Valley

ABSTRACT
This is an application requesting for an Administrative Supplement to Enhance Diversity for the NIH U01
HL160274 grant. The proposed combined clinical and bioinformatics studies, although within the scope of the
parent grant, are not in the funded Specific Aims. The long-term goal of the candidate is to pursue a career as
a physician-scientist with a focus on servicing underserved communities. This supplement aims to obtain new
insights on how exposomic factors correlate to heart failure with preserved ejection fraction (HFpEF) risk
factors by building upon the existing aims from the parent award. Specifically, the proposed study aims to use
the increased prevalence of diabetes, hypertension, and obesity observed in Hispanic patients, and their
corresponding exposomic factors – including climate, environment, diet and lifestyle, medical interventions,
body morphology, physical activity, and inflammation – to test the biological markers of HFpEF with their
associated socioenvironmental determinants. By understanding the exposomic factor contributions, we will
gain insights into patient-specific treatment to improve their long-term health outcomes. The candidate and the
mentors have outlined a comprehensive training goal and have assembled a strong Mentoring Team to ensure
that the candidate will receive valuable technical training, research experience, and career development.
Therefore, this proposed supplement will provide the candidate a platform for career development while, in
parallel, fostering diversity by reducing underrepresentation in the workforce of scientific research, as outlined
in the FOA (PA-18-906). New insights obtained from the proposed supplement will highly complement and
enhance the project in the parent grant.

Public health relevance
Project Narrative This is an application requesting for an Administrative Supplement to Enhance Diversity for the NIH U01 HL160274 grant. The proposed combined clinical and bioinformatics studies, although within the scope of the parent grant, are not in the funded Specific Aims. Our proposed study promises to contribute both technically and conceptually to the overall understanding of the molecular mechanisms underlying HFpEF patients in underserved communities.